Shared Resource Group1: Genomics and Statistics

The Biostatistics Shared Resource (BSR) supports the research of 43% (n=62/144) of all program-aligned members of the St. Jude Comprehensive Cancer Center (SJCCC), of which 61% (n=38/62) have cancer related peer-reviewed funding, and 39% (n=24/62) hold cancer-related, non-peer-reviewed funding. These SJCCC members were drawn from all five of our Center Programs. The resource provides collaborative, statistical support to Center members for peer-reviewed, funded grants and statistical designs for institutional clinical, translational and pre-clinical studies, as well as for laboratory investigations. BSR biostatisticians are active members of SJCCC Programs and provide members with access to state-of-the-art, innovative statistical science; a centralized randomization system; access to SAS for Windows; technical support for a web-based distributed data management system. The Cancer Center Support Grant provides critical funding that is necessary to ensure centralization of function and stability of support; thus, permitting cost effective, timely collaborations.

Public health relevance
The Biostatistics Shared Resource provides the SJCCC with outstanding support for the appropriate statistical design and analysis of both clinical and laboratory cancer research. The input of this resource is critical to ensure that all study objectives are addressed with statistical confidence and subsequent publications are supported by appropriate statistical analyses providing valid inferences.